Administrative Core

The Administrative Core represents the executive, coordinating, and oversight component of the Brigham
and Women’s (BWH) Hospital Roybal Center for Therapeutic Optimization using Behavioral Science. The Core
has a multi-disciplinary, multi-institutional governance and leadership organizational structure. It is housed at
Brigham and Women’s Hospital and its Executive and Steering Committee consist of individuals from
medicine, geriatrics, psychology, behavioral science, statistics, digital technologies, implementation research,
health equity and other disciplines. The Center leadership has complementary expertise across Stages 0 to IV
of the NIH Stage Model of Behavioral Intervention Development and includes researchers both from within and
outside traditional academic environments.
Despite challenges of the COVID-19 pandemic and other administrative days, the BWH Roybal Center
has created an effective administrative infrastructure and by the end of the last (and first) funding period will
have supported 11 trials, testing 8 distinct interventions in 7 age-related conditions involving 39 different
investigators, more than 60,000 patients and producing 2 dozen peer-reviewed publications. This provides a
very strong foundation for the continuation of our Center. Building upon the learnings from these activities and
in response to the evolution of the Roybal program RFA, we seek to further develop the Center’s ability to test
interventions in more diverse settings and to engage with an even more nationally representative set of
investigators. These objectives will be achieved through the following Specific Aims: (1) to facilitate and
manage the scientific, administrative and fiscal needs of the Roybal Center’s translational research program;
(2) to refine the process of soliciting research proposals from investigators around the US in order to continue
the growth of the pipeline of studies conducted at the Roybal Center; (3) to facilitate obtaining funding from
industry, federal and non-profit agencies to test promising behavioral interventions in the real-world setting;
and (4) to build a collaborating community to advance the science of behavior change by leveraging basic
behavioral and social science principles to enhance the use of evidence-based medications.
In summary, the Administrative Core of BWH Roybal Center for Therapeutic Optimization using Behavioral
Science will build upon its demonstrated success and now proposes to test an even broader set of principle-
driven interventions, in more diverse settings, and to engage with an even more nationally representative set of
investigators in partnership with a novel collaboratory of NIA-funded research centers and large
implementation partners.